Vasopressin 2 receptors in the bat bladder: effects of age and biological sex on expression and function

ABSTRACT
Nocturia, frequent night-time urination, has a major negative impact on sleep and health, particularly in the
elderly. Changes in vasopressin release and the expression of vasopressin receptors are significant
contributors to nocturia. A vasopressin analogue, desmopressin, is used clinically to treat nocturia.
Desmopressin dosing must be titrated according to biological sex and age. However, its underlying
mechanism of action is poorly understood because (1) vasopressin receptors are expressed in multiple
tissues with multiple effects and (2) vasopressin release and vasopressin receptor expression vary with age
and sex. In this pilot study, we propose to use the long-lived fruit bat, Carollia perspicillata, as a model
system to establish the age- and sex- based changes in vasopressin signaling, with an emphasis on
vasopressin 2 receptor (V2R) levels in the kidney and bladder. It has been established that the fruit bat is
closer to humans in reproductive biology and neurobiology than rodents are to humans, suggesting that the
bat may be a useful animal model. Critically, the fruit bat can live well over ten years in captivity, making it a
potentially important model organism for studies of cumulative age-related changes in organ structure and
function. In Aim 1, we will establish the prevalence of nocturia and polyuria in our bat colony and determine
the distribution and expression levels of V2 receptors in the kidney and bladder wall and the impact of
biological sex and age on these levels. In Aim 2, we will determine the impact of desmopressin treatment on
urine output and osmolality and bladder capacity and contractility in young and elderly animals of both sexes.
We will test the hypothesis that changes in urine output and osmolality and bladder function in animals of
different age and sex depend on changes in vasopressin receptor expression levels. This pilot study will
provide feasibility data on the fruit bat's utility as a model of natural aging in urobiology. Our results will
support more detailed studies of the neuro-uro-biological mechanism of vasopressin for the study of targeted
therapeutics in conditions such as nocturia.

Public health relevance
NARRATIVE Age-dependent changes in vasopressin release and vasopressin receptor expression can lead to clinical conditions such as nocturia, but treatments are challenging because (1) vasopressin receptors are expressed in multiple tissues with multiple effects and (2) receptor expression varies according to age and biological sex. In this pilot project, we will use the long-lived fruit bat as a model system to define the sex- and age- specific changes in vasopressin expression and the expression and function of vasopressin receptors in the kidney and bladder. This pilot study will be a foundation for more detailed of targeted therapeutics for urogenital system aging, including nocturia.